Methotrexate treatment of Arthritis caused by Chikungunya virus (MARCH): A randomized controlled trial of methotrexate versus placebo in the treatment of chronic arthritis after chikungunya infection

ABSTRACT
Chikungunya virus (CHIKV) is an alphavirus spread by mosquitos that causes persistent arthritis in
approximately 25% of people two years after initial infection. There is currently no standard evidence-based
treatment for CHIKV chronic arthritis. The French guidelines suggest the use of methotrexate in the treatment
of chronic CHIKV arthritis however there are no randomized placebo-controlled trials of methotrexate to
support this recommendation. Our long-term goal is to guide the evidence-based treatment of CHIKV arthritis.
The main goal of this proposal is to determine the efficacy and histopathologic effects of 6 months of
methotrexate (n=100) versus placebo (n=50) on synovitis in chronic CHIKV arthritis in Colombia in a
randomized controlled trial. Our central hypothesis is that methotrexate will significantly decrease chronic
CHIKV arthritis disease severity compared to placebo and suppress leukocyte accumulation and inflammatory
cytokine expression in synovial tissue. This hypothesis will be evaluated in 2 specific aims. In Aim 1, we will
determine the efficacy of oral methotrexate treatment versus placebo for 6 months in chronic CHIKV arthritis.
In Aim 2, we will determine the effect of methotrexate on synovial inflammation by obtaining synovial biopsy
samples before and during treatment. Rationale: This work will define the role and mechanism of
methotrexate in the treatment of chronic CHIKV arthritis with the goal of advancing the field towards an
evidence-based standard treatment. The potential broader impact of this work is the potential identification of
the pathologic mechanism of chronic viral arthritis and a possible therapeutic option.

Public health relevance
NARRATIVE The objective of this proposal is to determine the efficacy and histopathologic effects on synovitis of 6 months of methotrexate (n=100) versus placebo (n=50) therapy for chronic CHIKV arthritis in Colombia in a randomized controlled trial. Our central hypothesis is that methotrexate will significantly decrease chronic CHIKV arthritis disease severity compared to placebo and suppress leukocyte accumulation and inflammatory cytokine expression in synovial tissue. In Aim 1, we will determine the efficacy of oral methotrexate treatment versus placebo for 6 months in chronic CHIKV arthritis, in Aim 2, we will determine the effect of methotrexate on synovial inflammation by obtaining synovial biopsy samples before and after treatment in order to precisely define the role of methotrexate in the treatment of chronic CHIKV arthritis with the goal of advancing the field towards an evidence-based standard treatment.